Cancer Disparity Collaborative Supplement: Integrating electronic health record and patient-generated health data for breast cancer and cardiovascular disease risk assessment among diverse multiet...

PROJECT SUMMARY/ABSRACT
This supplement is being submitted in response to PAR-22-114 to conduct an ancillary study to SWOG 1904,
a multicenter randomized controlled trial of chemoprevention decision support among women with atypical
hyperplasia (AH) or lobular carcinoma in situ (LCIS). Our overall objective is to develop an equitable and efficient
approach for risk assessment of breast cancer and atherosclerotic cardiovascular disease (ASCVD). Women
with high-risk breast lesions, such as AH or LCIS, have up to a 4- to 10-fold increased risk of invasive breast
cancer compared to women with non-proliferative breast disease and derive a 70-80% relative breast cancer
risk reduction with anti-estrogen therapy for chemoprevention. A potential barrier to chemoprevention uptake
includes competing comorbidities, such as ASCVD. Racial/ethnic differences exist for multiple chronic diseases;
for example, Black and Hispanic women are at lower risk for breast cancer but have poorer clinical outcomes
compared to non-Hispanic Whites, but they are at higher risk for ASCVD risk factors, including hypertension,
dyslipidemia, and diabetes. Current recommendations are for individuals at intermediate-high risk for ASCVD to
receive cholesterol-lowering medications with statin therapy for the primary prevention of cardiovascular events.
Among racially/ethnically diverse women with AH or LCIS, we found that mean 10-year risk of breast cancer was
higher than ASCVD (9.14% vs. 6.69%, p<0.001); however, among women at high-risk for both conditions, uptake
of statins was higher compared to anti-estrogen therapy for chemoprevention (58% vs. 21%, p<0.001). To
address under-utilization of chemoprevention among women at high-risk for breast cancer, the risks and benefits
of anti-estrogen therapy could be placed in the context of medications used to treat or prevent other chronic
conditions, such as statins for ASCVD.
We have developed a web-based RealRisks decision aid (DA), which includes personalized breast cancer
risk assessment and decision support for chemoprevention. The DA is available in English and Spanish and has
been rigorously tested in racially/ethnically diverse women with varying health literacy. Using Fast Healthcare
Interoperability Resources (FHIR), we have developed a RealRisks user interface (UI), which allows patients to
access and verify their medical records to facilitate breast cancer risk assessment. Our current aims are: 1) To
conduct user evaluations in up to 24 high-risk women with AH or LCIS to develop a FHIR-enhanced RealRisks
UI to assess both breast cancer and ASCVD risk by extracting clinical data from the electronic health record
(EHR); 2) To assess the effect of the FHIR-enhanced RealRisks UI on patient activation, risk perceptions, and
usability, in a feasibility pilot study among 55 diverse multiethnic high-risk women with AH or LCIS. This
preliminary work will inform a future intervention trial through the SWOG NCORP Research Base, which may be
applied to both high-risk women and breast cancer survivors. Our goal is to develop equitable strategies for risk
assessment of multiple chronic diseases to improve health outcomes and reduce health disparities.

Public health relevance
PROJECT NARRATIVE The overall objective of this administrative supplement is to develop equitable strategies for risk assessment of breast cancer and atherosclerotic cardiovascular disease (ASCVD) to improve health outcomes and reduce health disparities. We propose to refine an existing RealRisks decision aid, which is actively being evaluated in on ongoing multicenter SWOG trial, to facilitate breast cancer and ASCVD risk assessment among racially/ethnically diverse high-risk women with atypical hyperplasia or lobular carcinoma in situ. We hypothesize that juxtaposing ASCVD and breast cancer risk with statin and chemoprevention uptake, respectively, may enhance the use of these medications for primary prevention.